Mouse Metabolic Measurement System

Mouse Metabolic Phenotyping System
Abstract
Metabolic assessment is central to the study of many murine models of disease including classic metabolic
disorders diabetes, obesity and anorexia, but metabolic profiling has increasing proven important in the study of
atherosclerosis, fatty liver disease, cancer and more recently in the study of autoimmune disorders, aging and
development. Columbia University Irving Medical Center (CUIMC) has been a leading center for the study of
metabolism in murine models of disease and physiology for more two decades. The success of the research
efforts by Columbia faculty has been anchored by the building and maintenance of a scientific infrastructure that
permits state-of-the art assessment of metabolic phenotypes of mice by scientists with widely varying areas of
focus, expertise and resources. The Naomi Berrie Diabetes Center has been central in building this infrastructure
and NIH-funded programs in Diabetes, Cancer and Obesity have helped staff and maintain the varied facilities.
This application proposes to maintain that infrastructure and grow its capabilities with the purchase of a Sable
Promethion Metabolic Phenotyping System for the study of mice. The system will permit high temporal resolution
in assessment of metabolic function (O2 consumption and CO2 production), motion, water intake, movement,
feeding behavior, body weight and with additional sensors body temperature and continuous glucose monitoring.
The 16 cage system will provide state-of-the-art technology in an integrated format with flexibility that is not
offered by other systems. The system will be overseen by Dr. Anthony Ferrante and be incorporated into the
existing infrastructure supported by the Naomi Berrie, the Columbia Diabetes and the NY Nutrition Obesity
Research Centers. It will replace an antiquated system that currently is not operating and will expand the ability
of a large group of productive Columbia investigators to complete funded proposals and provide new
opportunities for further metabolic studies.

Public health relevance
Project Narrative The study of mice models of human disease has provided important insights and led to the development of important therapies for many common diseases. The study of diabetes, liver disease, heart disease and cancer among common disorders benefit from measuring metabolic parameters including energy expenditure, feeding behavior, body weight changes and blood glucose. The proposed new equipment will permit Columbia researchers studying these and other diseases to perform cutting edge research that measure these important metabolic parameters.